TITAN KRIOS PERFORMANCE IN NUS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. A new Titan Krios from FEI was installed at the National University of Singapore (NUS) in the spring time of 2010. We will assist their establishment of the cryoEM facility and train their staff and users.